Neurodegenerative diseases and the role of green space: A deep learning assessment

PROJECT SUMMARY
Alzheimer’s disease and related dementias (ADRD) have well-established risk factors such as physical activity (PA),
depression, and hypertension (HTN). These risk factors disproportionately affect racial minority populations, but the
mechanisms underlying racial health disparities are not well understood. In this, geographic factors could be key, as PA,
depression and HTN are strongly affected by geographic exposures, including green space. However, green space is
typically measured with questionnaires, which have substantial error, or satellite-based indexes that are nonspecific and
provide no information on the type of vegetation (e.g., tree vs. grass), nor whether the vegetation is within view at the street
level. As a result, no study has quantified the contribution of green space to racial disparities in ADRD. And while novel
technologies such as Google Street Views (GSV) imaging are promising data sources for capturing unique measures of
green space, managing, processing, and analyzing high-dimensional data present significant logistical and analytical
challenges, especially when linking these data to existing data from large prospective cohorts. Finally, we need to understand
green space in the context of other potentially correlated geographic exposures, or the urban exposome—the totality of life-
course geographic exposures (the set of green space, air pollutants, noise, built environment, and social environment)—to
estimate which factors drive health. This proposal will address these challenges by using GSV imaging to assess the effect
of green space on PA, depression, and HTN, as well as subsequent ADRD risk within the Multi-Ethnic Study of
Atherosclerosis (MESA)—a 10-year longitudinal study of 6,814 men and women without clinical cardiovascular disease at
baseline from 4 racial/ethnic groups (Non-Hispanic White, African-American, Chinese, and Hispanic). Aim 1 will quantify
the effect of specific aspects of green space (e.g. trees, grass, shrubs, plants) on ADRD and cognitive decline and evaluate
whether these associations differ according to race/ethnicity. Aim 2 will determine the indirect effect of green space on
ADRD that is mediated through PA, depression, and HTN. Aim 3 will quantify exposome associations with ADRD and
cognitive decline using untargeted data-driven approaches in conjunction with dimension reduction techniques and evaluate
whether they differ according to race/ethnicity. This research plan is complemented by a training plan that builds on the
applicant’s background in epidemiology and biostatistics and includes new training in (1) implementing deep learning
algorithms to analyze high-resolution geographic data, (2) cognitive function epidemiology, and (3) developing and refining
data-driven approaches to perform exposome-informed epidemiological studies. These combined plans will successfully
prepare the applicant for an independent research career focused on identifying modifiable geographic determinants of
ADRD in diverse populations using innovative measures of geographic context.

Public health relevance
Project Narrative Green space or trees and natural vegetation can provide mental health benefits and possibly lower risk of neurodegenerative diseases such as Alzheimer’s disease and related dementias (ADRD); however, green space is often measured poorly in epidemiologic research. I propose to integrate high-resolution images from Google Street Views to derive ground-level objective measurements of green space into a diverse prospective cohort study using deep learning algorithms, mediation analysis and geographic mixtures. This research will enable unprecedented perspectives on exposures that drive ADRD and related cognitive decline risk, and will provide translational insights into potential interventions to optimize opportunities for ADRD prevention and reduce racial disparities in ADRD.